Postdoctoral Research Associate Training Program (PRAT)

The NIGMS Postdoctoral Research Associate Training (PRAT) Program's overarching goal is to provide high quality postdoctoral research training in the basic biomedical sciences, in NIH intramural research laboratories, to a diverse group of postdoctoral fellows to prepare them for leadership positions in biomedical careers. The research projects focus on NIGMS mission-related areas of basic biomedical science. These include biological chemistry, biophysics, bioinformatics, cellular and molecular biology, developmental biology, genetics, immunology, neuroscience, pharmacology, physiology, and technology development. Studies employing a variety of research organisms are encouraged.

Publications are included as part of the IR research mentor's reports.

All PRAT Fellows are IRTAs.

PRAT Fellows and Preceptors, Class of 2020, effective September 1, 2020:

Tiffany Zarrella, PhD
Anupama Khare, PhD (NCI)

Pam Head, PhD
Charles Venditti, MD, PhD (NHGRI)

Sezen Meydan-Marks, PhD
Nicholas Guydosh, PhD (NIDDK)

Danielle Chisolm, PhD
Markus Hafner, PhD (NIAMS)

Evan Hart, PhD
Geoffrey Schoenbaum, MD, PhD (NIDA)

Marcos Ramos-Benitez, PhD
Daniel Chertow, MD, MPH (CC)

Omar Soler-Cedeno, PhD
Yarimar Carrasquillo-Garcia, PhD (NCCIH) (2020)
Zheng-Xiong Xi, MD, PhD (NIDA) (2021)

Andrew Moehlman, PhD
Richard Youle, PhD (NINDS)

Andrew Beaven, PhD
Alexander Sodt, PhD (NICHD)

Rachael Philips, PhD
John O'Shea, MD (NIAMS)

PRAT Fellows and Preceptors, Class of 2021, effective September 1, 2021:

Britney Hardy, PhD
Anupama Khare, PhD/Kumaran Ramamurthi, PhD (NCI)

Luis Colon-Cruz, PhD
Shawn Burgess, PhD (NHGRI)

Rachel Cosby, PhD
Todd Macfarlan, PhD (NICHD)

Aisha Burton, PhD
Gisela Storz, PhD (NICHD)

Veronica Ryan, PhD
Michael Ward, MD, PhD (NINDS)

Rodolfo Flores-Garcia, PhD
Hugo Tejeda, PhD (NIMH)

Saniya Rattan, PhD
Humphrey Yao, PhD (NIEHS)

Liz Garcia-Peterson, PhD
Xiaoling Li, PhD (NIEHS)

PRAT Fellows and Preceptors, Class of 2022, effective September 1, 2022:

Jonathan Chow, PhD
Yavin Shaham, PhD (NIDA)

Amber Lockridge, PhD
John Hanover, PhD (NIDDK)

Theodore Busby, PhD
Thomas Misteli, PhD (NCI)

Ian Lewis Morgan, PhD
Keir Neuman, PhD (NHLBI)

Riley Zeinert, PhD
Gisela Storz, PhD (NICHD)

Sierra Marker, PhD
Martin Schnermann, PhD (NCI)

John Joseph O'Malley, PhD
Mario Penzo, PhD (NIMH)

Stephanie Lena Sarbanes, PhD
Antonia Roll-Mecak, PhD (NINDS)

PRAT Fellows and Preceptors, Class of 2023, effective September 1, 2023:

Jong Park, PhD
Brant Weinstein, PhD (NICHD)

Ashira Lubkin, PhD
Michail Lionakis, PhD (NIAID)

Adriana Alexander, PhD
Humphrey Yao, PhD (NIEHS)

Julian Rey, PhD
Peter Basser, PhD (NICHD)

Melesse Nune, PhD
Susan Buchanan, PhD (NIDDK)

Stefan Katharios-Lanwermeyer, PhD
Anupama Khare, PhD (NCI)

Elisha Segrist, PhD
Yasmine Belkaid, PhD (NIAID)

Ryan Cupo, PhD
Richard Youle, PhD (NINDS)